ADRDL Diagnostic testing support for the FDA CVM VET-LIRN program

4/12/23
Project Summary
The South Dakota Animal Disease Research and Diagnos�c Laboratory (SD ADRDL) will serve as a Whole
Genome Sequencing (WGS) core laboratory for the Veterinary Laboratory Inves�ga�on and Response
Network (Vet-LIRN). The main aim of this project is to perform WGS on isolates obtained from working
with 5 partner source labs: North Carolina State University Center for Veterinary Medicine, Michigan
State University Veterinary Diagnos�c Laboratory, Minnesota Veterinary Diagnos�c Laboratory, Iowa
State University Veterinary Diagnos�c Laboratory, and Oklahoma Animal Disease Diagnos�c Laboratory.
These partners will culture Salmonella enterica, Escherichia coli, Staphylococcus pseudintermedius, and
other relevant organisms from veterinary matrices. Once sent to the SD ADRDL, iden�ty will be veriﬁed
via MALDI-TOF before extrac�ng genomic DNA and performing WGS. Sequence will be uploaded to NCBI
bioprojects designated by Vet-LIRN Program Oﬃce.
Vet-LIRN has been tasked with developing AST and WGS assays that will allow for increased
understanding of an�microbial resistance within veterinary samples. This knowledge will be used to
develop evidence-based interven�ons that have demonstrated reduc�ons in resistance.
5U18FD006558 Page 1 of 1

Public health relevance
4/12/23 Project Narrative The South Dakota Animal Disease Research and Diagnos�c Laboratory (SD ADRDL) will serve as a Whole Genome Sequencing (WGS) core laboratory for the Veterinary Laboratory Inves�ga�on and Response Network (Vet-LIRN). Working with 5 partner source labs, SD ADRDL will perform WGS analysis on Salmonella enterica, Escherichia coli, Staphylococcus pseudintermedius, and other relevant organisms, uploading to NCBI bioprojects designated by Vet-LIRN Program Oﬃce. This data will be used to surveil for genes important to an�microbial resistance. 5U18FD006558 Page 1 of 1